Mitigation of preanalytic factors influencing brain tumor protein phosphorylation

PROJECT SUMMARY
Diffuse gliomas, including oligodendroglioma, astrocytoma, and the highly malignant glioblastoma (GBM), are
the most common type of primary malignant brain tumor. Increased activation of the phosphatidylinositol 3
(PI3)-kinase/AKT/mTOR signaling pathway is common in GBM and appears to be one mechanism of
malignant transformation of tumors from lower grade diffuse glioma to GBM. Given the importance of this
pathway in disease, several therapeutic strategies that target it are being tested in early phase clinical trials. To
maximize benefit and minimize toxicity to these therapies, however, accurate and robust biomarkers for patient
stratification and assessment of disease response to therapy are needed. Analysis of protein phosphorylation
provides integrated, functional information about signaling pathway activity. The goal of this proposal is to use
biospecimen sciences to identify and mitigate the preanalytic factors, including intratumoral heterogeneity,
tissue acquisition, and confounding non-neoplastic cells, that can obscure accurate analysis of protein
phosphorylation in diffuse glioma. We hypothesize that accurate assessment will require small, well-preserved
and biologically targeted tumor biopsies. To investigate this hypothesis we propose a multidisciplinary team of
investigators with expertise in the acquisition and analysis of multiple and image-guided biopsies, brain tumor
biology, biobanking, neuropathology, imaging, biostatistics, and neuro-oncology. First, we investigate
innovative approaches to target tumor biopsies to biologically aggressive tumor regions using pre-operative
MR spectroscopic imaging and intra-operative tumor metabolism using 5-aminolevulinic acid (ALA)-based
imaging. Second, we use clinically validated assays and state-of-the-art single cell mass cytometry to evaluate
PI3K/AKT/mTOR signaling pathway activity and determine the contribution of non-neoplastic cells to overall
phosphoprotein levels. Third, using the evidence-based methodologies and approaches we develop, we will
investigate the prognostic significance of PI3K/AKT/mTOR signaling pathway activity as determined by protein
phosphorylation in diffuse glioma and in patients treated with an mTOR inhibitor by integration with our Phase
2 clinical trial targeting the PI3K/AKT/mTOR signaling pathway (NCT02023905).

Public health relevance
PROJECT NARRATIVE The success of precision medicine is dependent on biomarkers that permit accurate and reliable stratification of patients and assessment of response to therapy. Preanalytic variables such as tumor heterogeneity and tissue handling, however, can obscure clinical assessment of biomarkers. The proposed studies use biospecimen sciences to develop evidence-based standards to assess phosphoprotein levels for evaluation of oncogenic signaling pathway activity in diffuse glioma, a highly heterogeneous disease.